The role of personality in cognitive aging and dementia

FUNDED PARENT PROJECT SUMMARY/ABSTRACT: R01AG060933
Dementia is the fifth most common cause of death in the United States. Personality traits, specifically
Neuroticism and Extraversion, are implicated in cognitive decline and forms of dementia such as Alzheimer’s
disease and related disorders (ADRD). The long-term goal is to better understand why personality is such a
strong predictor of cognitive decline and dementia. The overall objective in this R01 is to disentangle the role of
personality change as an indicator of dementia from personality as a risk factor that precedes cognitive
decline. This R01 proposes to augment a funded prospective longitudinal study of cognitive decline and
dementia by assessing markers of personality in the form of emotion, negative thought, and social interaction
patterns in daily life rather than relying solely on broad surveys of personality traits. The central hypothesis is
that this novel approach will allow us to disambiguate the role of personality change as an indicator from
personality differences as risk factors. The rationale for the proposed research is that current approaches
measure too infrequently, are delayed in detecting personality change, and are too broad to identify the
specific, potentially modifiable behavioral, thought, and emotional patterns that pose risks for decline and
dementia. Guided by preliminary measurement work, we will test everyday markers of Neuroticism and
Extraversion alongside commonly used trait measures. Specific aims extended from this hypothesis include: 1)
Test the prediction that everyday emotions, thoughts, and behaviors map onto trait Neuroticism and
Extraversion, 2) Test the prediction that everyday markers of Neuroticism and Extraversion are more sensitive
than trait measures in detecting personality change, and 3) Test the prediction that both trait and everyday
measures of personality will predict subsequent cognitive decline but that everyday markers will identify
specific emotional, thought, and behavioral patterns which may be amenable to intervention. The approach is
innovative, in the applicant’s opinion, because it tests theory-based predictions related to personality and
cognitive decline and dementia, leverages a large prospective longitudinal sample, and tests a novel
measurement approach against standard methods. The proposed research is significant because it is
expected to advance and expand understanding of personality as related to cognitive decline and ADRD. Such
knowledge has the potential to direct interventions to specific targets most associated with risk and identify
everyday indicators of cognitive impairment.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the identification of personality-related risk factors for and indicators of cognitive decline and dementia is expected to increase understanding of possible interventions and increase early detection. The proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge to protect health. It directly aligns with the NIA’s Strategic Directions for Research on Aging goals of better understanding the effects of personal factors such as personality on aging, including mechanisms through which these factors exert their effects.